Assessing miRNA expression in the Corticolimbic System of Major Depressive Disorder

Contact PD/PI: Vladimirov, Vladimir I
Abstract:
The objective of this proposal is to investigate the biological mechanisms by which microRNAs (miRNAs)
contribute to major depressive disorder (MDD). MDD is a severe mental disorder and the single most common
risk factor for suicide. Recent genome-wide association studies (GWAS) of large samples of MDD have for the
first time identified robust genetic associations with major depression. However, the biological mechanisms by
which these increase the risk for major depression are still unknown. Additionally, most genetic variants
associated with MDD fall outside of the protein coding transcriptome, suggesting that their functional impact is
likely to affect gene expression levels rather than protein structure. MiRNA are highly expressed in the brain and
were shown to play an important role in the pathology of psychiatric disorders including MDD and their canonical
functions are to control gene expression levels. Despite their importance, however, profiling of miRNA expression
in large postmortem brain samples for various neuropsychiatric disorders including MDD across different brain
regions currently do not yet exist.
Thus, in this application we propose to use miRNA sequencing to assess miRNA expression in one of the
largest postmortem brain samples of major depression in the world. The sample has been extensively
characterized clinically, genetically, and molecularly and provides a unique resource for examining the
neurobiological mechanisms by which genetic factors contribute to major depression directly in the primary
affected tissue. Our miRNA data will be integrated with an ongoing RNA sequencing data generated in the same
subjects to identify miRNA/mRNA pairs with important disease functions. Our aims are to: 1) carry out miRNA
sequencing of the subgenual anterior cingulate cortex (sACC) and amygdala in 200 recurrent MDD cases and
200 matched controls, 2) test whether genome-wide significant SNPs from GWAS of MDD are associated with
miRNA expression across these key regions of the brain, 3) identify miRNA whose expression is associated with
major depression and suicide and perform a series of univariate, multivariate (network), and data integration
analyses to further elucidate miRNA role in the neuropathology of MDD, 4) replicate our top miRNA (FDR ≤5%)
in an independently ascertain postmortem brain sample of 50 MDD cases and 50 matched controls. In aim 4 we
will also perform series of exploratory analyses to identify the cellular mechanism by which risk MDD variants
affect miRNA/mRNA interactions. We hypothesize that a major mechanism contributing to the etiology of major
depression is through the ability of risk MDD variants to affect miRNA expression and functions. By explicating
the mechanisms by which risk MDD variants lead to increase risk of major depression, we will provide novel
targets for intervention in the disease process and, therefore, a more rational basis for improved treatments.

Public health relevance
Contact PD/PI: Vladimirov, Vladimir I Narrative: The main goal of this application is to identify the neurobiological mechanisms by which risk genetic variants associated with major depression (MDD) from large GWAS of MDD affect miRNA expression and functions in a large postmortem brain sample composed of 200 MDD cases and 200 matched controls.